TGF-regulated EMT

DESCRIPTION (provided by applicant): The epithelial-mesenchymal transition (EMT), in which cells undergo a switch from a polarized, epithelial phenotype to a highly motile fibroblastic or mesenchymal phenotype is fundamental during embryonic development and can be reactivated in a variety of diseases including fibrosis and cancer. EMT is associated with changes in cell-cell adhesion, remodeling of extracellular matrix, and enhanced migratory activity, all properties that enable tumor cells to metastasize. Numerous cytokines and autocrine growth factors, including TGFβ, have been implicated in EMT. Despite intensive transcriptional array analysis of human tumors, the identity and validation of 'EMT signature genes' remains elusive. We have elucidated a novel, post-transcriptional pathway by which TGFβ modulates expression of EMT-inducer proteins and EMT itself. We identified that heterogeneous nuclear ribonucleoprotein E1 (hnRNP E1) binds to a structural, 33-nucleotide TGFbeta-activated translation (BAT) element in the 3'-UTR of two bona fide EMT-inducer transcripts, disabled-2 (Dab2) and interleukin-like EMT inducer (ILEI), thereby repressing their translation in NMuMG and EpRas cells, two established in vitro models of EMT. In this pathway, TGFβ activates a kinase cascade terminating in phosphorylation of Ser43 of hnRNP E1 by isoform-specific stimulation of protein kinase Bβ/Akt2, inducing its release from the BAT element and causing translational activation of Dab2 and ILEI mRNAs. Modulation of hnRNP E1 expression, or its post-translational modification, alters not only TGFβ-mediated translational activation of the target transcripts, but also EMT. Recently, we have purified the ribonucleoprotein (mRNP) complex binding to the BAT element and have identified elongation factor 1A1 (EF1A1) as a second, functional component of this translational silencing pathway. We hypothesize that translational regulation of Dab2 and ILEI, as well as other EMT-inducer transcripts, constitutes a TGFβ-inducible post-transcriptional regulon mediated by hnRNP E1 and EF1A1, which functionally regulates EMT during tumorigenesis. The goal of this proposal is to use this mRNP complex as a model target of TGFβ signaling, to delineate its regulation of protein synthesis in response to TGFβ and to determine its functional significance in mediating tumorigenesis and metastatic progression. PUBLIC HEALTH RELEVANCE: The epithelial-mesenchymal transition (EMT) is a fundamental process during normal embryonic development but it can also be aberrantly re-activated in a variety of diseases including fibrosis and cancer. TGFβ is one of the growth factors implicated in EMT. The successful pursuit of the studies proposed herein will elucidate the molecular mechanism through which TGFβ mediates EMT and will provide insight into the design of strategies and therapeutics aimed at its prevention in pathological situations.

Public health relevance
Narrative The epithelial-mesenchymal transition (EMT) is a fundamental process during normal embryonic development but it can also be aberrantly re-activated in a variety of diseases including fibrosis and cancer. TGFβ is one of the growth factors implicated in EMT. The successful pursuit of the studies proposed herein will elucidate the molecular mechanism through which TGFβ mediates EMT and will provide insight into the design of strategies and therapeutics aimed at its prevention in pathological situations.